IGF::OT::IGF: OPTION PERIOD. CTN DISSEMINATION INITIATIVE: MOVING SCIENCE FROM RESEARCH TO PRACTICE. POP: SEPTEMBER 15, 2017 - SEPTEMBER 14, 2019. N01DA-17-2248.PURPOSE: TO REPLACE DR. ANTON BIZZELL

IGF::OT::IGF: OPTION PERIOD. CTN DISSEMINATION INITIATIVE: MOVING SCIENCE FROM RESEARCH TO PRACTICE. POP: SEPTEMBER 15, 2017 - SEPTEMBER 14, 2019. N01DA-17-2248